Defining the neural basis for persistent obesity

Project Summary/Abstract.
Despite the prevalence of obesity in the United States, how obesity strengthens brain circuits that reinforce
feeding is not known. This K01 proposal will identify specific neural circuits and subcircuit mechanisms that
enhance feeding and are co-opted in obesity. While prior research has focused on obesity-linked adaptations
in brain regions that drive homeostatic feeding, adaptations in brain regions involved in hedonic, motivated
feeding may be dysregulated in obesity and contribute to ongoing food seeking and weight gain. For instance,
the nucleus accumbens (NAc) is a brain region that regulates feeding and reward, and human and rodent
literature have revealed alterations in NAc activity in obesity, along with disrupted NAc synaptic plasticity
mechanisms. Preliminary data in this proposal demonstrates that NAc activity was selectively increased in a
subpopulation of neurons known to invigorate reward, D1-receptor expressing neurons (D1SPNs), in obese mice
during food seeking. Further, inhibiting NAc D1SPNs output decreased food seeking and prevented diet-induced
weight gain. Enhanced D1SPN activity was driven by increased intrinsic excitability and pre-synaptic
glutamatergic drive. Together these data suggest a model in which enhanced excitatory NAc inputs drive food
seeking in obesity. Yet it remains unclear which input(s) is/are responsible for increased NAc activity in obese
mice, whether all NAc D1SPNs are aberrantly activated or if select ensembles drive food seeking, and lastly,
what synaptic mechanisms underlie these adaptations. The central hypothesis of this proposal is that
enhanced excitatory input to NAc D1SPNs drives food seeking and obesity through attenuated synaptic
depression of glutamatergic inputs. The experiments outlined here will use in vivo optogenetics,
electrophysiology, genetic manipulations, novel operant behavioral paradigms, and a mouse model of diet-
induced obesity to test this hypothesis in the following Aims: Aim 1 will determine which NAc input(s) drive food
seeking and weight gain in obese mice. Aim 2 will investigate how select ensembles of NAc D1SPNs that are
activated during food seeking drive enhanced feeding in obesity. Aim 3 will define a potential mechanism
underlying changes in NAc plasticity in obese mice, and determine how such plasticity underlies food seeking
and weight gain. Together, these experiments represent a major step forward towards understanding how
obesity alters brain circuits, and why it so difficult for people to lose weight and keep it off.

Public health relevance
Project Narrative While obesity affects more than a third of American adults, we still do not understand how obesity changes the brain to drive feeding and further weight gain. The research proposed here is relevant to public health because it will study neural circuits that reinforce feeding and reveal how they are strengthened in obesity. This aligns with NIDDK’s mission to support research and research training focused on metabolic diseases including obesity, and will ultimately lead to more targeted therapies to prevent weight gain.